Quantifying Bone and Skin Movement in the Residual Limb-Socket Interface of Individuals with Transtibial Amputation Using Dynamic Stereo X-Ray

Individuals with lower extremity amputation (LEA) often experience relative motion between their
residual limb and the prosthetic socket, such as vertical translation and axial rotation, which can cause inefficient
dynamic load transmission from the distal prosthetic components to the residual limb. This can lead to
significant secondary consequences, such as pain, gait deviations, and discomfort that limit mobility and
autonomy. Assessments of the relative motion between the bone and the prosthetic socket have been performed,
but there is little existing data on dynamic, in vivo residual limb-socket kinematics since most investigations
have been performed using non-dynamic testing protocols, static measurements, or with unvalidated surface
marker-based motion capture systems. Dynamic Stereo X-ray (DSX) is an advanced imaging technology that can
quantify 3D bone movement and tissue/liner deformation inside a prosthetic socket during dynamic activities.
It can achieve sub-millimeter accuracy of bone pose (position and orientation) measurement during functional
movements by combining 3D models derived from CT scans with movement data from biplanar x-ray video.
There is a substantial gap in our understanding of the complex mechanics of the residual limb-socket
interface during dynamic activities that limit the ability to improve prosthetic design. Our 4-year goals for this
project are to develop the analytical tools to quantify both the dynamic, in-vivo kinematics between the residual
limb and socket, as well as the mechanism of residual tissue/liner deformation. In order to validate the sensitivity
of this methodology to differences in socket suspension, we will evaluate 2 suspension systems: elevated vacuum
(EV) and simple suction. We hypothesize that an efficient and highly accurate method to quantify the dynamic
interaction between the residual limb and prosthetic socket will be sensitive enough to distinguish between
different types of prosthetic socket suspension, which will further the biomechanical understanding of socket
design. To do so, the investigators will address the following aims: (1) To optimize the DSX procedural setup for
the accurate tracking of the prosthetic socket, skeletal kinematics, and tissue/liner deformation; (2) To quantify
the relative motion between the residual tibia and the prosthetic socket during dynamic activities; and (3) To
measure the deformation of the skin and liner in the prosthetic socket during dynamic activities.
To address these aims, we will first employ a cadaver study to optimize the placement of an array of radio-
opaque beads and markers on the socket, liner, and skin to simultaneously assess both dynamic skeletal
movement and residual tissue/liner deformation. Five cadaver limbs will be utilized in an iterative process to
develop an optimal marker setup. Stance phase gait will be simulated during each DSX session to induce bone
movement and skin/liner deformation. The number and placement of markers will be evaluated after each
session to refine the marker placement to track skin/liner deformation and skeletal movement. Once an optimal
marker setup is identified, 21 subjects with transtibial amputation will be fit with a socket capable of being
suspended via both EV and traditional suction. Subjects will undergo a 4-week acclimation period and then be
tested at the DSX facility at Rutgers University. DSX will be utilized to track skeletal and skin/liner motion under
both suspension techniques during 3 dynamic activities: treadmill walking at self-selected speed, fast walking
(10% faster), and a step-down movement. The performance of the two suspension techniques (active EV and
normal suction) will be tested by quantifying the 3D bone movement of the residual tibia with respect to the
prosthetic socket and quantifying liner and soft tissue deformation at the socket-residuum interface.
By using the analytical tools for a highly accurate, in-vivo assessment of residual limb-socket motion, we
can provide vital foundational information to aid in the development of new methods and techniques to enhance
prosthetic fit that have the potential to reduce secondary physical comorbidities and degenerative changes that
result from complications of poor prosthetic load transmission.

Public health relevance
Individuals with lower extremity amputation are often challenged by complications that arise from poor prosthetic fit, including movement of the residual limb in the socket, known as pistoning. Pistoning can lead to gait instability, skin problems, and pain. Different prosthetic suspension systems have been developed to decrease this motion, including elevated vacuum suspension, which utilizes a pump to draw air from the socket. However, scientific analyses to understand the movement between the limb and socket in elevated vacuum systems have yet to be performed with a high level of accuracy. This study will use a state-of-the art imaging technique, known as dynamic stereo x-ray, to quantify the 3D movement of the residual limb in the socket. This information is critical for advancing prosthetic treatments to reduce secondary conditions and degenerative changes that result from poor prosthetic fit.